CHARACTERIZATION OF DEVELOPMENTAL MUTANTS CAUSED BY RETROVIRAL INSERTION

To identify and isolate developmental genes, we carried out insertional mutagenesis studies in transgenic mice derived from retrovirally infected embryonic stem (ES) cells. The 412 strain segregates 23 proviruses, 3 of which cause recessive prenatal lethality. The molecular and phenotypic analysis of the 412-k and the 412-r insertional mutations are currently underway.